Methods Core

ABSTRACT – METHODS CORE
The ASPIRES Methods Core (MC) brings together investigators from diverse and complementary backgrounds
to collectively address design, implementation, methodological, and technological challenges that impede
progress toward effectively reducing the youth suicide rate. Our transdisciplinary team includes experts in
study design methodology for behavioral and population interventions, predictive analytics to improve clinical
decision making, development of digital health interventions, implementation science, qualitative methods,
integration of multi-level data elements representative of patient and community health, and geospatial
modeling of environment and social structure on population health. The MC capitalizes on substantial
institutional infrastructure and intellectual capital at both The Abigail Wexner Research Institute (AWRI) at
Nationwide Children’s Hospital (NCH) and The Ohio State University (OSU), and Co-Leaders Drs. Brock,
McAlearney, and Lin have each led both specialized and multidisciplinary teams with broad impact spanning
multiple areas of health. The MC will work with ASPIRES investigators to facilitate in a pediatric population 1)
development and testing of novel and scalable interventions and research-generated resources with significant
appeal for stakeholders; 2) rapid and widespread dissemination of new, effective practices; 3) continuous
improvement of suicide prevention interventions delivered in real-world settings; 4) interdisciplinary team
science to facilitate novel and convergent solutions to intractable suicide prevention challenges; and 5) training
of students, fellows, early career, and advanced investigators from diverse backgrounds to increase the
diversity of investigators conducting cutting-edge translational suicide prevention research. Our MC provides a
methodological anchor connecting all ASPIRES projects, and our transdisciplinary team with substantial
expertise, resources, and infrastructure at both NCH and OSU will ensure that all ASPIRES projects are
conducted with scientific rigor and broadly disseminated. Creative partnerships with the Zero Suicide Institute
and the OSU CCTS Pilot Project Program augment outreach, engagement, and dissemination. Methodological
and technological advances from our MC provide innovative approaches to overcoming challenges facing
behavioral interventions for reducing the youth suicide rate. Synergistic study design elements across
ASPIRES projects provide unique opportunities to study implementation and efficacy aspects of suicide
prevention interventions across primary, specialty, and acute care. Collectively, these developments support
innovative and rigorous evaluation of ASPIRES interventions and provide the groundwork for further design
and refinement of implementation strategies necessary to scale these interventions in future studies.

Public health relevance
NARRATIVE The ASPIRES Center will implement, evaluate, and optimize suicide prevention interventions and practices across the continuum of primary, specialty, and acute care to improve youth mental health and reduce the suicide rate. The Methods Core (MC) is essential to that process in promoting the advancement and application of rigorous and innovative methods to test and evaluate the impact and implementation of these evidence-based interventions. The overall goal of the MC is to strengthen the rigor, quality, and implementation success of the research projects within ASPIRES while simultaneously developing and promoting innovative methods for suicide prevention research.